Underlying mechanisms of obesity-induced obstructive sleep apnea

Obstructive sleep apnea (OSA) is a highly prevalent disease with major neurocognitive and cardiovascular
sequelae. Obesity is a major risk factor for OSA, but the underlying mechanisms remain unclear. Given the
rising prevalence of obesity and the lack of adequate therapies for some afflicted patients, further mechanistic
work is clearly required. Bariatric surgery is being done increasingly with compelling outcome data emerging;
however, clinical response to weight loss is highly variable. In some patients, OSA is not present at baseline,
despite morbid obesity, in other patients, OSA resolves following bariatric surgery, while other patients have
persistence of OSA despite weight loss, and still other patients can experience re-emergence of OSA in long
term follow-up studies after bariatric surgery. OSA can occur due to several major pathophysiological factors
including pharyngeal anatomy, pharyngeal dilator muscle dysfunction, unstable ventilatory control, end-
expiratory lung volume and arousal threshold. As a result considerable complexity exists in the obesity/OSA
relationship, suggesting the need for further research. First, we will perform a baseline evaluation of
pathophysiological traits among obese people prior to weight loss surgery. Because some people will have
OSA and some will not, we will define the potential mechanisms underlying OSA and potential protective
mechanisms among obese people without OSA (pharyngeal critical closing pressure Pcrit primary outcome).
Second, we will re-evaluate these same individuals from the standpoint of sleep study and pathophysiological
traits six months following bariatric surgery after a variable degree of weight loss. We anticipate that some OSA
patients will have resolution of OSA whereas others will have persistence of disease. For non-OSA patients
undergoing weight loss, we will have a positive control group which will allow us to account for non-specific
effects of weight loss. This aim will allow us to test the hypothesis that pharyngeal mechanics is the predominant
mechanism whereby weight loss leads to improvement in OSA. Third, we will perform magnetic resonance
imaging during wakefulness at functional residual capacity, total lung capacity and residual volume on
participants at baseline and 6months following bariatric surgery. This aim will allow us to perform
structure/function assessments in our participants, to define the impact of weight loss on pharyngeal anatomy,
and to quantify the lung volume dependence of the upper airway before and after weight loss. The acquired
data will also be used for computational modeling including dynamic assessment of pharyngeal function during
tidal breathing. As a result of the proposed research, we are confident that we will gain major insights into the
as yet unanswered question “why does obesity (sometimes) cause sleep apnea”. This research will have major
therapeutic implications as it will allow us to individualize therapy for afflicted patients.

Public health relevance
Narrative summary Sleep apnea has major health consequences and although linked to obesity is not simply a matter of excess body weight. We propose to understand the mechanisms underlying why some obese people have sleep apnea and others do not and to determine why sleep apnea resolves following weight loss in some but not all people. This research will ultimately allow us to develop new treatments for sleep apnea in an individualized manner based on underlying mechanisms.